Functional Immune Phenotyping of Sepsis Patients: Integrating Microphysiological Assays, Omics and In Silico Modeling

Abstract
Sepsis is defined as life-threatening organ dysfunction caused by a dysregulated host response to infection
with over 1.7 million cases/year and >350,000 deaths in the US. Neutrophils are important contributors to
the dysregulated immune response and play a critical role in sepsis-induced organ failure through
interactions with the vascular endothelium resulting in barrier disruption and increased neutrophil trafficking
into vital organs. While neutrophils are vital to host defense, neutrophil dysregulation has a critical role in
organ damage through release of proteases, neutrophil extracellular traps (NETs), and reactive oxygen
species (ROS), which damage host tissue leading to organ failure. Drug development has been hindered for
multiple reasons including the heterogenous nature of sepsis. There is now a consensus that the host
response to sepsis is highly diverse among patients, and this heterogeneity impacts immune function and
response to infection. To develop more effective and targeted therapeutics, a better understanding of
neutrophil characteristics and identification of distinct neutrophil subpopulations is needed. To our
knowledge, no studies have examined the impact of different neutrophil phenotypes on the functional
consequences of neutrophil-endothelial interactions in sepsis or linked these functional consequences to
altered omics. We hypothesize that functional neutrophil phenotypes in sepsis patients regulate their
ability to interact with the vascular endothelium and traffic into critical organs. Employing organ-on-
chip analysis, we identified three neutrophil functional phenotypes (Hyperimmune, Hypoimmune and Hybrid)
in sepsis patients based on ex vivo neutrophil adherence/migration patterns. These functional phenotypes
were associated with distinct proteomic signatures and differentiated sepsis patients by important clinical
parameters related to disease severity. The Hyperimmune group had increased oxygen requirements,
increased mechanical ventilation, and longer ICU length of stay compared to the Hypoimmune and Hybrid
groups. We will use a synergistic combination of our organ-on-chip, clinical data, proteomics, and in silico
modeling to provide important mechanistic insight into neutrophil functional phenotypes in sepsis. The aims
of this study are: 1) Characterize the temporal progression of neutrophil functional phenotypes in patients to
ascertain whether neutrophil functional phenotypes shift as sepsis progresses, 2) Test the hypothesis that
neutrophil functional phenotypes are organ specific in their interactions with different organ-specific
endothelial cells, 3) Determine the impact of sepsis patient phenotypes on response to therapeutics. We will
identify FDA-approved drugs that target differentially expressed proteins within and across phenotypes.
Using human patient neutrophils offers a unique platform to identify omic and phenotypic differences in drug
responses between neutrophil phenotypes. The proposed studies will determine the impact of neutrophil
phenotypes on therapeutic responses.

Public health relevance
Project Narrative Sepsis is a major health issue and leading cause of death in hospitals. There are no specific drugs for treating sepsis and therapeutic development is hindered because of the heterogeneous nature of the disease and the presence of multiple immune phenotypes that impact neutrophil-endothelial cell interaction, vascular barrier disruption, and neutrophil migration. The goal of this study is to use a synergistic combination of our organ-on-chip assays, clinical data, proteomics, and in silico modeling to provide important mechanistic insight into the impact of neutrophil phenotypes in sepsis patients and identify important therapeutic targets for precision (personalized) medicine.